RFA-CK-22-001, Investigation of Monkeypox and Other Zoonotic Diseases in the Democratic Republic of the Congo (DRC) - 2022

Project Summary
The goals of this project are to improve the scientific understanding and reduce the clinical burden of
Monkeypox (MPX) and other zoonotic diseases in Democratic Republic of the Congo (DRC). This
should directly support the U.S. CDC mission of strengthening public health surveillance systems
globally to prevent the spread of emerging diseases. This project will rely upon the Kinshasa School of
Public Health’s considerable experience with training public health practitioners, conducting scientific
research trials, and supporting the DRC Ministry of Health to accomplish its objectives. The project will
be framed around a laboratory-based surveillance system for MPX in DRC to collect accurate case burden
data. We will expand upon this framework by evaluating new training methods for health workers,
improving geographic data, and assessing new diagnostic platforms when available. We will use our
relationships with health systems in highly affected areas to conduct clinical trials of care regimens,
vaccines, and anti-viral therapies. We will perform serosurveys in high-risk and survivor populations to
better understand transmission risk factors, viral persistence, and sequalae. We will work with key groups
in these areas to identify wildlife reservoirs of MPX and collect qualitative data on the attitudes and
behaviors of key populations living in these communities. We will work with the government of DRC to
improve the ability to respond to outbreaks quickly by preemptively training response workers,
developing health promotion networks, and responding to misinformation rapidly. We will share results
with national stakeholders and other nations interested in being better prepared for responding to endemic
and imported MPX cases.

Public health relevance
Project Narrative Zoonotic diseases like Monkeypox and Ebola virus disease are a significant public health threat in Democratic Republic of the Congo (DRC) and have a high risk of international exportation. This project aims to improve the ability of DRC to respond to zoonotic diseases by developing rigorous surveillance systems, investigating medical countermeasures and clinical treatments, identifying key risk factors in primary transmission of disease, and creating a resilient interdisciplinary public health workforce.